Increased Extraction Capacity for Molecular Section

Vet-LIRN Network Capacity-Building Project and Equipment Grants (U18)
PAR-23-202
Increased Extraction Capacity for Arizona Veterinary Diagnostic Laboratory Molecular Section
Project Summary/Abstract-
The Arizona Veterinary Diagnostic Laboratory (AZVDL) is seeking funding to purchase an Indical
IndiMag2 to enhance its nucleic acid extraction capability and capacity, thereby strengthening
its emergency surge testing for signiﬁcant animal food/feed emergency events. Veterinary
diagnostic laboratories play a critical role in protecting both animal and public health, especially
during large-scale foodborne disease outbreaks or contamination incidents.
Funding through the Vet-LIRN Network Capacity-Building Project and Equipment Grants (U18) is
essential to expand AZVDL’s ability to respond eﬀectively to such emergencies. This support will
enable AZVDL to improve its diagnostic capabilities by acquiring advanced equipment.
The COVID-19 pandemic has demonstrated that veterinary laboratories are uniquely positioned
to provide high-throughput testing during public health crises, as they routinely handle large-
scale diagnostic procedures for zoonotic and animal diseases. By enhancing its capacity, AZVDL
will be better equipped to provide real-time detection of pathogens or contaminants in animal
food and feed, helping to prevent outbreaks that threaten food safety, public health, and
economic stability.
This funding initiative also aligns with the goals of the Food Safety Modernization Act (FSMA),
which emphasizes proactive measures to detect and prevent foodborne illnesses. Upgrading
AZVDL’s infrastructure will not only improve its response to emerging threats but also
contribute to the broader national network of veterinary laboratories dedicated to safeguarding
both animal and human populations.

Public health relevance
Vet-LIRN Network Capacity-Building Project and Equipment Grants (U18) PAR-23-202 Increased Extraction Capacity for Arizona Veterinary Diagnostic Laboratory Molecular Section Project Narrative- The Arizona Veterinary Diagnostic Laboratory (AZVDL) is requesting funding to purchase an Indical IndiMag2 to enhance its nucleic acid extraction capabilities and emergency surge testing capacity for large-scale animal food/feed emergencies. This funding, under the Vet-LIRN Network Capacity-Building Project and Equipment Grants (U18), is critical for AZVDL to respond eﬀectively to foodborne outbreaks, ensuring rapid detection of pathogens or contaminants to safeguard public health and food safety. By upgrading its infrastructure, AZVDL will align with the Food Safety Modernization Act (FSMA) goals, strengthen its diagnostic capabilities, and contribute to the national veterinary laboratory network’s ability to protect animal and human populations during emergencies.